REGULATION OF MYOCARDIAL GROWTH AND DEATH BY THE HIPPO PATHWAY

Summary
The Hippo signaling pathway is an evolutionarily conserved signaling pathway that controls organ size and
tumorigenesis by regulating cell growth and death. We have shown that each component of the Hippo pathway
is intimately involved in the pathogenesis of heart failure. YAP, the nuclear effector of the Hippo pathway, is
transiently activated in response to pressure overload (PO) but downregulated during the chronic phase of PO
and heart failure. Cardiac specific downregulation of YAP inhibits cardiac hypertrophy but promotes heart
failure during the acute phase of PO, suggesting that endogenous YAP is salutary and mediates compensatory
hypertrophy during the acute phase of PO. Although YAP is downregulated during the chronic phase of PO,
forced activation of YAP at this stage is detrimental and promotes heart failure, due to de-differentiation of
cardiomyocytes. Thus, YAP can be either protective or detrimental in a context-dependent manner during PO.
However, it remains to be shown what makes YAP either salutary or detrimental during PO in the heart. Our
preliminary results suggest that YAP promotes compensatory cardiac hypertrophy by stimulating glycolysis
through upregulation of GLUT1 in the heart during the acute phase of PO, in a manner similar to aerobic
glycolysis, namely the “Warburg effects” in cancer cells. Here we hypothesize that endogenous YAP mediates
compensatory hypertrophy and survival of cardiomyocytes in the presence of PO through transcription of
GLUT1 and consequent upregulation of glycolysis and biosynthetic molecules. YAP acts cooperatively with
TEAD and HIF-1 and is involved in upregulation of GLUT1 that is activated during the acute phase of PO but
inactivated during the chronic phase of PO due to differential availability of the partner transcription factors of
YAP. To test these hypotheses, we will: 1. (a) Demonstrate that endogenous YAP plays an essential role in
mediating upregulation of glycolysis in response to acute PO. (b) Demonstrate that activation of YAP induces
accumulation of glycolytic intermediates through GLUT1- and PKM2-dependent mechanisms. (c) Demonstrate
that YAP-induced upregulation of GLUT1 is essential for the maintenance of glycolysis and consequent
upregulation of compensatory cardiac hypertrophy in response to acute PO. 2. Demonstrate that YAP-induced
upregulation of GLUT1 is mediated through direct binding of YAP to TEAD and/or HIF-1 and resultant
cooperative actions during acute PO. We will use genetically altered mouse models, cultured adult
cardiomyocytes, metabolomic analyses, transcriptome analyses and ChIP sequencing analyses to address
these issues. Successful completion of this project will provide novel information about the molecular switch
that controls the glycolytic pathway and compensatory hypertrophy in the heart and how YAP differentially
controls signaling mechanisms to mediate both salutary and detrimental effects in the heart during PO.

Public health relevance
Lay Summary The heart becomes thicker in response to high blood pressure and other forms of stress in order to maintain its function of ejecting the blood to the whole body system. Together with coordinated stimulation of other mechanisms to ensure survival of heart cells and blood supply to them, this is an essential mechanism during the early phase of stress by which the heart maintains its function even in the presence of stress. We here study the mechanism by which the heart maintains its function in the presence of high blood pressure. We will test our hypothesis that a mechanism that stimulates the use of glucose for energy supply and production of building blocks coordinates the adaptation of the heart to stress so that the heart can continue to eject the blood. The knowledge obtained from this investigation should be useful in the development of novel interventions to protect the heart against stress.